Somatic Mosaicism in Human Development, Aging, and Diseases

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Somatic Mosaicism in Human Development,
Aging, and Diseases, organized by Drs. Jeong Ho Lee, E. Alice Lee and Peter Campbell, with scientific
programming input from Keystone Symposia. The meeting will take place February 17–20, 2025 at the Beaver
Run Conference Center in Breckenridge, Colorado USA.
The study of somatic mosaicism is beginning to reframe our understanding of human genetics, development,
aging and the important links between genes and diseases. Comprehensive analysis of the genetic variation that
defines somatic mosaicism allows us to trace lineage evolution from the fertilized egg to human embryo to adult
organs, along with defining developmental and aging processes at single-cell resolution. It is recognized that this
field of study is at an early stage and requires advanced experimental and computational genomic technologies,
which is of particular relevance to the mission of the National Human Genome Research Institute (NHGRI). This
Keystone Symposia conference represents one of the first focused events on somatic mosaicism designed to
convene an interdisciplinary research community around this field and to bring together scientists and clinicians
from developmental and aging biology, bioinformatics, systems biology, genetics and genomics, who will
collaboratively explore the intersection of these diverse fields. The conference will also attract participation from
researchers in industry, who recognize the nascent translational opportunities in somatic mosaicism research.
The program will integrate diverse aspects of somatic mosaicism, connecting with genomics innovations,
mechanistic analyses and translational opportunities, all of which fall within the remit of NHGRI.

Public health relevance
PROJECT NARRATIVE It is now evident that somatic mosaicism occurs across all human tissues during development and aging, with potential links to cancer and non-malignant diseases, but there remains a significant gap in understanding the extent to which somatic mosaicism affects human development, aging and disease progression. The field has just begun to explore these disease connections and continues to rely heavily on sequencing and bioinformatic tools to accurately detect these mutation profiles in human organs and tissues. This Keystone Symposia meeting on Somatic Mosaicism in Human Development, Aging, and Diseases will bring together an interdisciplinary research community to address gaps in knowledge related to somatic mosaicism to address critical technological and conceptual questions that will support progress and translate into future benefits for patients.